Flexible Funding Model - MFRPS Maintenance and Food Protection Task Force for the Nebraska Department of Agriculture

Overall Project Summary
The Nebraska Department of Agriculture (NDA) Food Safety and Consumer Protection
(FSCP) aims to provide guidance for industry and training for regulators to be well
informed about FSMA requirements, reach and maintain conformance with all
standards, but with a specific focus on standard 6, and work to improve and implement
a functioning document control system.
Providing educational resources and supplement guidance will provide a consistent
understanding of regulations between regulators and industry. In correlation to
increased resources, the regulatory staff can focus more on compliance and
enforcement actions. NDA will retrain staff and review the current compliance and
enforcement procedures that work strongly with the resources NDA has readily
available.
Implementing and maintaining standard 6 elements will only be functional if all other
standard requirements are being implemented and maintained. An efficient document
control system will show how traceback and trace forward practices streamline and
demonstrate how all standards work fluidly together. Overall, the efforts towards
implementing and complying with MFRPS elements is to develop an integrated food
safety system that will prevent and reduce foodborne illness.

Public health relevance
RFA-FD-23-027 Protect Title: Flexible Funding Model - MFRPS Maintenance and Food Protection Task Force for the Nebraska Department of Agriculture Protect Narrative: Nebraska Department of Agriculture (NDA) Food Safety and Consumer Protection (FSCP) Manufactured Food Regulatory Program Standards (MFRPS) maintains a regulatory program with a framework that builds on uniformity and food safety. Maintaining a uniform inspection program that focuses on food safety and the public’s health will prevent and reduce food-borne illness hazards in facilities that manufacture, process, pack, or hold food for human consumption.